Telomere attrition and T cell aging in vaccine failure during HIV infection

SUMMARY
The overall goal of this proposal is to elucidate the mechanisms by which chronic HIV infection promotes telomere
attrition and T cell aging, leading to hepatitis B virus (HBV) vaccine hypo-responsiveness. To this end, we will use a
model that emulates HBV vaccine response in the setting of HIV infection. Since co-infection of HBV with HIV is
common and associated with an increased morbidity and mortality, HBV vaccine is required to prevent HBV co-
infection in HIV patients. However, HBV vaccine response in HIV-infected patients is often blunted with only 30-60%
seroconversion (HBsAb > 10 IU/ml) compared to 90-95% success rate in age-matched healthy subjects (HS). This
poor vaccine response is also observed with influenza and pneumococcal vaccinations in HIV patients and other
immunocompromised hosts, including the elderly. Recently, we have found that chronic HIV or HCV infection can
cause premature T cell aging, as evidenced by overexpression of the aging markers KLRG1, DUSP6, CD57, and
p16ink4a, dysregulation of age-associated noncoding RNAs GAS5/miR21 and, in particular, accelerated telomere
attrition - suggesting excessive proliferative turnover or inadequate telomere maintenance. Telomere integrity is a
key feature of linear chromosomes that preserves genomic stability and function, whereas telomere attrition is a
hallmark of cell aging or senescence that drives cell dysfunctions and apoptosis. While telomere length is maintained
in most cases by a telomerase that prolongs telomeric DNA, telomere-associated proteins (shelterins) protect
telomeres from unwanted DNA damage response (DDR). We investigated the mechanisms of telomere attrition in
the setting of HCV and HIV infections and discovered that the cellular expression and activity of telomerase are
intact, whereas the telomeric repeat binding factor 2 (TRF2) is significantly inhibited in CD4 T cells derived from
HCV- or HIV-infected patients. Since the role of TRF2 is to protect telomeres from unwanted DNA damage and
recruit DNA repair enzymes (e.g., telomerase) access/function at telomeres, we hypothesize that: i) the mechanisms
involved in TRF2 inhibition may accelerate telomere attrition and CD4 T cell aging during HIV infection; ii) TRF2
inhibition may result in poor access/function of telomerase at telomeres during HIV infection; and iii) TRF2-mediated
telomere attrition and CD4 T cell aging may play a pivotal role in the failure of HBV vaccine in HIV-infected patients.
To test this hypothesis, we will 1) define the mechanisms involved in TRF2 inhibition and telomere attrition in T cell
aging during HIV infection; 2) determine how TRF2-mediated telomerase transport to telomeres affects T cell aging
during HIV infection; and 3) determine the impact of telomere attrition and T cell aging on HBV vaccine failure during
HIV infection and whether restoring TRF2-mediated telomere sheltering and telomerase homing machinery can
rescue CD4 T cells from telomere attrition and restore cell functions. This translational study is significant in that it
will provide a working model to explore mechanisms underlying the diminished vaccine (immune) responses in many
chronic infectious and inflammatory diseases, including but not limited to HIV. Understanding these mechanisms
may uncover novel treatment targets to improve vaccine efficacy and/or immune responses in immunocompromised
hosts. It is thus clinically significant, timely, and relevant to the Veterans as well as public health.

Public health relevance
NARRATIVE Patients with HIV infection often do not respond well to HBV vaccinations, and this phenomenon is also observed in other immunocompromised hosts, including the elderly, but the overall efforts to boost vaccine hypo- responsiveness in these subjects have been futile - in part due to our poor understanding of the underlying mechanisms that blunt vaccine responses. We have shown that chronic HIV or HCV infection can accelerate premature T cell aging due to telomere attrition - a hallmark of cellular senescence; however, the underlying mechanisms remain largely unknown. In this proposal, we will investigate how chronic HIV infection induces telomere attrition and T cell aging and how these molecular changes lead to HBV vaccine failure during HIV infection. This study will enhance our understanding of the fundamental mechanisms underlying immune aging in chronic viral infection and develop effective means to restore immune competence and improve vaccine efficacy in HIV-infected patients. It will also provide insight into common mechanisms of vaccine hypo- responsiveness under other immunocompromised conditions. It is thus clinically significant and timely.